Targeting Cancer Initiating Cells in Multiple Myeloma

PROJECT SUMMARY/ABSTRACT
Candidate: The applicant is a physician scientist who is an assistant professor in the Hematology Division at
the University of Colorado Anschutz Medical Center. In the MD/PhD program at Oregon Health and Science
University, he performed benchtop translational research under the mentorship of Brian Druker, focused on
chronic myeloid leukemia. The applicant’s thesis investigated drug resistance mutations that develop in patients
treated with the kinase inhibitor imatinib. In fellowship at UCSF, he focused on the development of a novel CD46-
targeted antibody-drug conjugate (ADC) for multiple myeloma in the laboratory of Bin Liu.
Environment: At the University of Colorado, the applicant has joined with a mentoring team with cancer stem
cell expertise in primary mentor Craig Jordan and co-mentor Clay Smith. The applicant will continue close
collaboration with postdoctoral mentor Bin Liu and has established a new collaboration with myeloma initiating
cell expert William Matsui at Johns Hopkins. The Director of the myeloma clinical program at the University of
Colorado, Dr. Tomer Mark, is another project co-mentor and will help train the applicant to design clinical trial
protocols based on his laboratory findings. The applicant’s training plan during the period of this award includes
bioinformatics, immunology, biostatistics and responsible conduct of research coursework, as well as programs
in translational research, grant writing and clinical trial protocol development.
Research: Multiple myeloma (MM) is incurable with current treatments. This implies that “MM-initiating cells”
(MM-IC) survive and have ability to regenerate the disease. It is controversial whether MM-IC have an immature
phenotype or are rather genetically distinct subclones. Regardless, our current inability to eliminate MM-IC leads
to relapse and eventually death in all patients. When MM becomes resistant to protease inhibitors and
immunomodulatory drugs (aka “double-refractory”), the prognosis is poor. Thus, currently there is a need for (1)
curative therapy for MM and (2) effective treatments for double-refractory disease. The applicant’s long-term
goal is to address this need by developing new MM-IC targeted therapies. This proposal will test an ADC that
targets the cell surface complement inhibitor CD46. In theory, this ADC could be curative if CD46 is present on
MM-IC. Provocatively, the CD46 gene is located on chromosome 1q, which is often genetically amplified in MM
(1q+). This 1q+ is a high-risk feature and is present in most double-refractory patients. We found CD46 was
highest in MM patient tissue samples with 1q+. The central hypothesis of this proposal is that CD46-ADC has
unique potential to selectively eliminate 1q+ MM-IC. The first aim will determine if CD46-ADC can selectively
eliminate 1q+ genetic subclones. The second will determine if CD46-ADC can eliminate MM-IC. If supported by
data from this proposal, the results will be applied to patient care directly in clinical trials of CD46-ADC in MM.

Public health relevance
Narrative Multiple myeloma is an incurable, debilitating blood cancer that afflicts more than 30,000 Americans per year. We have developed a new anti-CD46 antibody drug-conjugate (ADC) targeting a highly expressed protein in high-risk and relapsed multiple myeloma. This research project will evaluate the full potential of this new therapy by testing for curative effect and ability to treat disease that is resistant to current therapies.